Programmable evolution of optogenetic systems

Project Summary: This project is specifically tailored for the candidate, Nhu Dao, to conduct biomedical
research. Nhu’s research involves evolving novel proteins that can be photo-cleaved using light, allowing for
uses in biological imaging, studying cellular and developmental biology, optically controlled 3D printing, and
more. Using a system that enables a gene to continuously evolve, only cells containing a gene that responds
to specific wavelengths (colors) of light will grow. This process can rapidly evolve this new class of proteins
at an unprecedented pace. Proteins resulting from this evolution will be characterized using techniques from
an undergraduate “Biochemical Techniques” course previously taught by the PI. The project uses hardware
from the parent grant with minor modifications, making the timing and feasibility ideal for undergraduate
research.
In addition to the research training experience, the candidate will undergo extensive training in ethics,
project management, learning/teaching-related skills, writing, presentation skills, interpersonal skills, and
more. This training will initially take place in a “boot camp” setting and then be expanded upon throughout the
year. Finally, this training and research will culminate in writing about the research in manuscript form and in
a poster that will be presented in several poster symposia. Combined, this experience will boost the
candidate’s career, preparing her for success in biomedical research in a 4-year program, graduate school,
and beyond.

Public health relevance
Project Narrative: The candidate, Nhu Dao, will evolve a new class of light-responsive proteins at unprecedented speeds to control chemical or biological processes, enabling precise control over the time and location of these events. Producing these new proteins has broad implications, such as, enabling novel approaches to study cellular and developmental biology, and have material science applications in optically controlled 3D printing. In addition, using this approach to evolve fluorescent and photocleavable proteins paves the way for producing many superior versions or versions with entirely new functions.